Development of Radiofluorination Methods and Prosthetic Groups Suitable for Quick Iterative Constructions of PET Tracer Analogs in Rapid Radiopharmaceutical Development and SAR Study

Project Summary
The screening of biologically active substrates’ analogs and derivatives represents an eƯective and straightforward
strategy in new drug discoveries, as such strategy provides Structure Activity Relationship (SAR) study data that
can be useful in identifying the most promising drug structures. The screening could also be incorporated into High
Throughput Experiments (HTE) to facilitate rapid research process, and sometimes could generate unexpected
ﬁndings from screening to inspire new drug designs. Radioﬂuorinated Positron Emission Tomography (PET) tracers
are an important type of radiopharmaceuticals that are used in PET imaging, which could provide valuable
diagnostic data in the early stages of disease progressions. Even though the beneﬁts of screening large numbers of
drug candidates’ analogs apply to the development of both nonradioactive pharmaceuticals as well as
radiopharmaceuticals, the challenges in radiosynthesis can sometimes present obstacles in utilizing such strategy
in novel PET tracer development. This is especially a concern in 18F-labeled radiopharmaceutical development, as
the poor nucleophilicity of the [18F]ﬂuoride ion exacerbates these radiosynthetic challenges. To promote the
utilization of quick candidates screening strategy in 18F-labeled PET tracer development, the ﬂuorine-18 nuclide
must be incorporated at late-stages of the synthesis in a manner that is fast (to avoid decay loss) and selective (to
allow for the construction of PET tracer analogs with diƯerent functional groups for SAR studies). This can be done
either via 1) radioﬂuorination methods that are functional group compatible, or via 2) the utilization of robust and
selective 18F-labeled prosthetic groups. Progress in both categories have been reported by many groups in recent
years. My proposal focuses on the further developments of both new labeling methods and prosthetic groups, and
to construct large numbers of 18F-labeled PET tracer analogs in a quick and iterative manner via these new
methods/prosthetic groups for biodistribution evaluation in order to support radiopharmaceutical development via
quick screening strategy. To be speciﬁc, I propose to develop late-stage direct radioﬂuorination method to
synthesize [18F]ﬂuorohydrin substrates via organophotoredox-mediated reactions. I also propose to develop new
prosthetic groups such as radiolabeled isocyanate prosthetic groups and new strained alkynes for Strain-
Promoted Azide Akyne Cyclizations (SPAAC). These proposed method/synthon developments will promote quick
and iterative constructions of new PET tracer analogs for biodistribution evaluations, facilitate SAR studies, and
have the potential to promote rapid development process of radiopharmaceuticals.

Public health relevance
Narrative New functional group compatible radioﬂuorination methods and new robust selective prosthetic groups will promote quick iterative constructions of PET tracer candidates’ analogs, facilitate SAR studies and rapid radiopharmaceutical development process.